Shared Resource Management

PROJECT SUMMARY/ABSTRACT – SHARED RESOURCE MANAGEMENT
The FCCC Shared Resource Management (SRM) team provides essential administrative oversight and support
of FCCC Shared Resources (SRs). Centralizing SRs provides FCCC members with cost-effective access to
expertise, cutting-edge instrumentation, and new methods. SRM provides experienced administrative leadership
and operational policies to execute the following aims: 1) ensure all SRs deliver quality and cost-effective
services to FCCC members, 2) provide staffing, training, equipment, and space required for SRs to perform
cutting-edge service, 3) carry out thorough annual review of the SRs to meet the research needs of FCCC
members, 4) provide Senior Leaders with recommendations for investments and improvement of SRs and 5)
assure that SRs keep pace with technological advancements and outsourcing opportunities. To achieve these
aims, each SR is advised by a Facility Advisory Committee (FAC), which reports their deliberations, including
responses from user surveys, to the governing Facility Parent Oversight Committee (FPOC) consisting of senior
faculty. The FPOC then conveys its recommendations to the Chief Scientific Officer and Cancer Center Director,
who make policy and operational decisions that are implemented through the Associate Director for
Administration and the Shared Resources Administrator. This process has been utilized by the SRM team to
steward the institutional investment of $7.5M for new equipment, $3.1M for renovations to improve the 11 CCSG
SRs, and $17.9M to support the operations of 11 SRs from 2019-2023. Several recommendations were
implemented that have improved SR functioning, including changing the leadership of three SRs and demoting
one poorly performing SR (the Genomics Facility; GF) to “developing” status, while it is reorganized. These
investments support all five scientific priorities and the Innovation and Discovery Pillars of the FCCC Strategic
Plan, as exemplified by successful efforts by the Biosample Repository Facility (BRF) to diversify its biosample
collection by accruing racially/ethnically diverse biospecimens from the portion of the catchment area adjacent
to the Health Sciences Campus. FCCC is requesting operating support for 11 established SRs: Biological
Imaging Facility (BIF), Biosample Repository (BRF), Biostatistics and Bioinformatics Facility (BBF), Cell Culture
Facility (CCF), Cell Sorting Facility (CSF), High Throughput Screening Facility (HTSF), Histopathology Facility
(HF), Laboratory Animal Facility (LAF), Molecular Modeling Facility (MMF), Population Studies Facility (PSF)
and Transgenic Mouse Facility (TMF). The SRM facilitated the use of these 11 SRs by 91% of FCCC members
across all three Research Programs, and enabled these SR to support 594 cancer-related publications, of which
143 (24.1%) are in high impact journals from 2019-2023. Future plans include: 1) restoration of the GF as a full
SR; 2) expand Inter-Cancer Center Sharing of Shared Resources 3) increasing SR usage by FCCC members
from all three campuses, 4) assuring rigorous oversight of SR functioning through active management of FAC
and FPOC membership, and 5) providing training opportunities for Master's students at Temple University.